Biological Science Program at the Gerontological Society of America's 2025 Annual Scientific Meeting

PROJECT SUMMARY
This proposal requests funding from the National Institute on Aging for the Biological Sciences (BioSci) Section Program at the 2025 Annual Scientific Meeting (ASM) of the Gerontological Society of America (GSA) in Boston, MA. Our aim for BioSci programming is to highlight the highest-quality aging research with a focus on Harnessing the Hallmarks of Aging. We believe that the best work in the field will emerge when basic researchers exchange information about health-related biology of aging with medical researchers and practitioners, psychologists, sociologists, and public policy experts. In turn, improvements in clinical care and public health are likely to result when gerontologists better understand basic mechanisms of aging and are exposed to the latest and best research with the promise of yielding interventions to ameliorate aging and age- related disease. We in the BS Section take our responsibility to expose our members, those of the Biological Sciences and the GSA at large, to well-communicated, cutting-edge science that ultimately serves to inform and improve the work of all who attend, very seriously. The ASM is situated uniquely in the U.S. to promote an interdisciplinary effort of this scope, and the 2025 November meeting in Boston will provide an outstanding opportunity to expand the number and multidisciplinary representation of participating scientists. The BS Section has demonstrated quantifiable success in producing a scientific program of the highest possible quality and providing a forum to engender interaction and exchange of ideas among scientists. In November 2025, we propose to intensify and extend our efforts, through a single-track meeting program featuring emerging concepts in the basic biology of aging; to promote discussion and networking among attendees across sections; and to feature talented early career investigators prominently in Biological Sciences symposia.. During the main meeting 14 (non-competing) oral sessions will be held. These sessions were devised by a team of ten Investigators recruited for their expertise and as leaders in aging research. Each member of the team will Chair a session and will participate in all aspects of the meeting organization, evaluation, and student engagement, under the mentorship of PI Curran. Poster sessions are scheduled so as not to compete with any talks. Along with GSA leadership, we have devised strategies to recruit and support 8 Early-Stage investigator travel awards.

Public health relevance
PROJECT NARRATIVE The Biology of Aging program at the Gerontological Society of America (GSA) 2025 Boston meeting is organized in accordance with the GSA’s mission to promote interactions between biologists and other scientists of multiple disciplines focused on aging, age-related disease, and the social, psychological, and public policy impacts of an aging society. The goals of the Biology of Aging program are to (1) present cutting-edge advances in biology of aging research that provide new avenues for translation to human well-being and extension of healthy human lifespan and (2) to expand the number and increase the quality of scientists actively participating in biology of aging research. Our program supports the development of early state investigators.